RNA Structure Modeling Using Physics and Sequence Comparison

Abstract:
RNA sequences have pervasive roles in biology and RNA molecules are also important
pharmaceuticals. Many of these RNA molecules function by use of specific structures, and these
structures are therefore conserved across evolution. With the availability of high throughput
methods to identify RNA transcripts and probe structure, there is a need to model these structures
to get the most information from available data. The goal of the Mathews lab is to develop
algorithms and software to model RNA structures, including secondary and tertiary structures.
We focus on using biophysical principles, and we are also at the forefront of incorporating
additional information in our models, including experimental mapping data and structure
conservation. Here, we will build on the foundation of prior work to develop new structure
prediction methods. We provide our software freely to the community and we rigorously test our
methods with close collaborations with experimentalists.

Public health relevance
Project Narrative: RNA structure is important in both human health and disease, including genetic diseases and infectious diseases. Here we are developing algorithms and software to predict and analyze RNA structure. This provides important information that can be used to understand disease mechanisms, target RNA with pharmaceuticals, and develop RNA-based pharmaceuticals.